Spatial and Temporal Adjuvant Delivery for Skin mRNA Vaccination

Abstract
The success of COVID-19 mRNA vaccines has showcased the effectiveness of this technology in
rapid design, manufacturing, and adaptation to emerging viral threats. However, several imitations
remain, including their instability requiring cold-chain storage that limits their global distribution, the
necessity for two doses for optimal efficacy, limited immunity to closely matched viral strains, and
quick-waning immunity following the initial two doses. These limitations can be potentially
addressed by potent adjuvants. However, traditional adjuvants, co-delivered with vaccines to
enhance antigen-presenting cell (APC) recruitment and functionality, are unsuitable for mRNA
vaccines, because the co-delivered adjuvant provokes innate immune responses that interfere with
mRNA translation, reducing its immunogenicity. Our recent investigation demonstrated that mRNA
vaccines, particularly when delivered intradermally, could be substantially augmented by adjuvant
delivery at different times and locations relative to mRNA vaccination, effectively circumventing the
interference with mRNA transcription and translation. The current proposal aims to determine
whether intranasal (IN) or intradermal (ID) delivery of a newly developed adjuvant can expand the
breadth and longevity of trivalent influenza (flu) mRNA vaccine administered via a microneedle
array patch (MNP). Specifically, we will construct a trivalent self-amplifying mRNA (saRNA) flu
vaccine, encapsulated within liposomes free of cationic or ionizable lipids using our proprietary
technology, and then loaded into our caved MNP after lyophilization. The antigen expression,
immunogenicity, and efficacy of this saRNA flu vaccine will be optimized and evaluated in mice.
Aim 2 will define the optimal time window of IN or ID adjuvant delivery following MNP-saRNA-
flu immunization. Antigens-specific T-cell responses and broad neutralization antibodies across
homosubtypic and heterosubtypic flu strains will be assessed and compared with or without the
adjuvant and between IN and ID adjuvant delivery. The longevity of the specific immune responses
will be also monitored over several months. Aim 3 will validate the efficacy of MNP immunization,
alongside delayed adjuvant delivery, against various flu viruses in young and aging mice. If
successful, the innovative strategy can be extended to other respiratory viral vaccines, such as those
for COVID-19, respiratory syncytial viruses, etc., broadening the breadth and efficacy of various
RNA-based vaccines delivered parenterally.

Public health relevance
Project Narrative The study aims to develop an innovative approach to induce broad immune protection against diverse influenza viruses. The strategy involves microneedle array-mediated immunization with trivalent influenza (flu) mRNA vaccine, followed by distant adjuvant delivery to avert interference with mRNA translation. This approach holds great promise to enhance the efficacy of various mRNA vaccines.